Effects of Tobacco & ENDS Policies on Patterns of Adolescent ENDS Use

Project Summary
States have responded to the emergence of electronic nicotine delivery systems (ENDS) through implementing
several types of policies specific to ENDS in addition to existing tobacco control policies. At present, the full
efficacy of both types of policies on ENDS and related tobacco use among adolescents is unknown. This
research study will use multiple, complementary statistical methods and a robust policy database to examine
the impact of relevant tobacco and ENDS-specific policies on ENDS use and related tobacco use among
adolescents. We will merge tobacco policy and ENDS-specific policy data from the American Nonsmokers’
Rights Foundation (ANRF) to evaluate the effects of these policies on patterns of adolescent ENDS and
related tobacco use (initiation, prevalence, duration, frequency, and cessation). We will accomplish this goal by
coding this policy database by state and year and combining it with data from the Population Assessment of
Tobacco and Health (PATH) and key time-varying measures from the U.S. Census. In our first pair of aims, we
will analyze this data using mixed effects models, using both within- and between-person effects. Respectively,
these two types of effects determine (a) whether adolescents change their ENDS and tobacco use after their
state of residence passes a particular policy, and (b) whether adolescents in a state that passes a policy
experience significantly different trajectories of ENDS and tobacco use relative to those in a state without the
policy. In addition, we will introduce sequence analysis, which allows for a more detailed depiction of
transitions into and out of ENDS and related tobacco use, and testing of differences in trajectories across
policies. We also will test for synergistic effects of policy; that is, whether the combination of any given policies
is particularly effective. In our second pair of aims, we assess policy effect differences across particular
respondent characteristics. First, we will consider whether parent contexts moderate the effects of policies.
Finally, we will conduct analyses of policy effects by key demographics: socioeconomic status, gender,
race/ethnicity, and rural/urban locale, which will permit the identification of related health disparities. Our
proposed research provides opportunities to test the impact of a rapidly evolving policy landscape on ENDS
outcomes and will contribute in the following ways. First, if certain policies or combinations of policies are
identified as efficacious, the results would provide evidence for broader adoption to curb current ENDS trends.
Second, the identification of possible health disparities in the benefits of policy implementation may not only
help health professionals work towards redressing disparities, but also identify policies that may “bypass”
social inequalities to provide comprehensive benefits to adolescents with long-term implications. Finally, this
study establishes a foundation for future research that will consider local policy variation, individual-level policy-
driven changes, and patterns of ENDS use.

Public health relevance
Project Narrative The emergence and growth in electronic nicotine delivery systems (ENDS) use during the past decade has created new public health challenges, and in response, state governments have implemented various policies, which together with existing tobacco control policies may shape patterns of ENDS use and related tobacco use among youth. By merging policy data with the longitudinal Population Assessment on Tobacco and Health (PATH) study, this project will use mixed-effects modeling and sequence analysis to identify the role of these policies in shaping ENDS use and related tobacco outcomes among U.S. adolescents. By examining the independent and interactive effects of tobacco and ENDS-specific policies, along with analyses of their effects by parental context and key demographic characteristics, this project has the potential to improve population health related to ENDS use among adolescents as well as address health disparities related to this issue.